Plug-and-Play Microsystem Enabling Highly Sensitive Analysis of Volatile Organic Compounds

Project Summary This SBIR Phase I project will investigate the technical feasibility of a microfabricated chip system for enabling on-site or in-field, highly sensitive analysis of volatile organic compounds (VOCs) in aqueous samples. The system consists of two chips in a tandem configuration. The first chip is designed to extract VOCs directly from water samples. The extracted VOCs are concentrated in the second chip, in which the concentrated VOCs can be released on demand for subsequent analysis. The Phase I specific aims are to design, fabricate, and characterize prototype chips, and to construct and characterize a proof-of-concept chip system. The final product will be a plug-and-play sample preparation/concentration microsystem with reusable chips, as well as having the interface for coupling to portable/handheld VOC analyzers/detectors. VOCs, including semi-VOCs, are one of the most important classes of environmental pollutants because of their significant health effects. On-site or in-field, real-time (or near real- time) measurement of VOCs in water is critical to timely assess environmental contamination, to develop effective risk management strategies, and to protect environmental and human health. Although many portable and handheld gaseous VOC detectors are commercially available, they are unsuitable for on-site or in-field, sensitive aqueous VOC analysis due to the lack of an automated miniature sampling/precocentration platform that can directly handle water samples. The proposed microsystem can be coupled to these portable/handheld instruments for addressing this critical unmet need. Moreover, it can be adjusted to extract and concentrate VOCs from other liquid samples for food quality/safety testing, biomonitoring, clinical diagnosis, etc. The microsystem can also be modified for concentration of VOCs from gaseous samples or for extraction and concentration of VOCs from solid samples. These will open the door to wider commercial utility.

Public health relevance
Project Narrative Contamination of water bodies by volatile organic compounds poses significant threats to public health and aquatic life. The proposed automated sample preparation and concentration microsystem will enable on-site or in-field, highly sensitive analysis of volatile organic compounds in aqueous samples, thereby helping protect human and environmental health.